Emerging Water Contaminants: Investigating and Mitigating Exposures and Health Risks

OVERALL SUMMARY/ABSTRACT
The Yale Superfund Research and Training Program (YSRTP) is driven by regulatory and community-based
concerns about emerging contaminants that affect water resources and drinking water supplies at multiple sites
in the US. The YSRTP has chosen to study 1,4-dioxane (1,4-DX) because of its common occurrence in
Superfund sites and drinking water supplies, and its USEPA and IARC classification as a possible human
carcinogen. The carcinogenic mechanism in the liver is unknown and its interaction with co-occurring and
carcinogenic water contaminants (1,1,1-trichloroethane, 1,1,1-trichloroethylene, and 1,1-dichloroethane) has
never been evaluated in either animals or humans. Given that liver cancer incidence rates have more than tripled
since 1980, there is an urgent need to evaluate whether emerging water contaminants, such as 1,4-DX, may be
contributing to this increase. Importantly, a lack of biomarkers of exposure to or the biological effects of 1,4 -DX
have hampered epidemiologic studies, risk assessment and setting standards for the contaminant. In addition,
the high polarity and low biodegradability of 1,4-DX restrict the ability to remove it from aquifer systems or
drinking water. Indeed, available treatment technology is both expensive and not readily applied to water
supplies. The YSRTP will foster problem-based, solution-oriented research related to 1,4-DX and its co-occurring
contaminants through innovative approaches to evaluate environmental occurrence and human exposure,
understand the underlying basis of adverse health effects, provide cost-effective remedial mitigation solutions
and ultimately set the stage for improved regulation of this emerging contaminant. The YSRTP will carry out
highly interactive projects to: (a) examine the health effects and biomarkers of exposure/effect to 1,4-DX (alone
and as a mixture with its co-occurring contaminants) in animal models and humans, and (b) develop systems to
monitor and mitigate human exposure to 1,4-DX in water. The biomedical science research projects will elucidate
the mechanism(s) associated with 1,4-DX liver toxicity and carcinogenesis in mouse and zebrafish models
(project 1), and exposure assessment and early biologic responses to 1,4-DX in human populations (project 2).
The environmental science and engineering research projects will create highly-sensitive and selective
electrochemical sensors for on-site, real-time detection of 1,4-DX (project 3) and develop innovative advanced
oxidation processes for mitigation technology (project 4). Successful completion of these innovative studies will
make a significant positive health impact by more clearly defining the health risks of 1,4-DX, elucidating
biomarkers of exposure, and establishing effective new ways to monitor and mitigate this important emerging
contaminant. Our systems approach integrates and links the research projects with the development of effective
communication and education of stakeholders, and training of future scientists to ensure the program has a far-
reaching impact on how emerging contaminants are addressed both in the US and globally.

Public health relevance
OVERALL PROJECT NARRATIVE The Yale Superfund Research and Training Program (YSRTP) is motivated by community-based concerns about emerging drinking water contaminants. The program will engage in problem-based, solution-oriented research related to 1,4-dioxane, an emerging water contaminant of particular concern because it is widespread and persistent in the environment, poorly regulated, has consistently shown carcinogenic effects, co-occurs with toxic chlorinated solvent contaminants (1,1,1-trichloroethane, 1,1-dichloroethane and 1,1,1-trichloroethylene), and is not mitigated using standard approaches. This proposal will address critical gaps in our understanding of cancer mechanisms, mixtures interactions, and detection and treatment technologies through innovative techniques that will inform risk assessment and regulatory standard-setting as well as help affected communities address health questions and remove this contaminant from water supplies.